Research Training in Biobehavioral Disturbances of Eating Disorders

PROJECT SUMMARY
This is the second renewal application for a T32 grant, “Research Training in Biobehavioral
Disturbances of Eating Disorders.” The primary goal of this training program is to train
postdoctoral (MD, MD/PhD, and PhD) fellows for careers as independent researchers in Eating
Disorders. An intensive three-year program is outlined in which fellows learn how to identify
key research questions, formulate hypotheses, and design and execute experiments that
effectively test those hypotheses. In the course of training, fellows acquire a range of skills
relevant to research methodology, including expertise in experimental design and statistical
analysis relevant to clinical research. Graduating fellows are able to present research projects
clearly in both written and oral forms as evidenced by publications and presentations. The
training program outlined, utilizing the outstanding faculty at Columbia University offers a
unique opportunity to future researchers in the field of eating disorders. The Columbia Eating
Disorders Research Unit has a long track record of recruiting and successfully training clinical
researchers with its success reflected in high rates of its trainees receiving K awards and
pursuing full-time academic careers. Also, the Columbia program has been successful at
recruiting MD researchers into the field of eating disorders, making it an unusual training
program in this specialized area. Prior to the start of this T32 program in 2013, research fellows
specializing in eating disorders at Columbia used other, more general research training
programs available within the department. As these programs became more focused on basic
science and neurobiology, they grew reluctant to accept candidates with interests in the field of
eating disorders whose interests may have been more clinically, behaviorally, and
translationally focused. The T32 program for eating disorders research has gotten off to an
excellent start, offering a comprehensive clinical research education program, for outstanding
candidates interested in eating disorders such as anorexia nervosa, bulimia nervosa and binge
eating disorder. The NIMH has identified eating disorders as an understudied area in need of
research initiatives. This application outlines a training plan for future researchers in this
important clinical area.

Public health relevance
PROJECT NARRATIVE This proposal, “Research Training in Biobehavioral Disturbances of Eating Disorders,” requests support for a three-year research fellowship program for post-doctoral MD and PhD scientists to train much needed future researchers specializing in eating disorders. Eating disorders are medically and psychiatrically serious illnesses in critical need of research into their underlying mechanisms and potential treatments. The training program outlined in this application describes a plan to successfully train clinical researchers in this specialized area.